Diversity Supplement: Personalized screening for lung cancer: the importance of co-existing chronic conditions to clinical practice and policy

PROJECT SUMMARY/ABSTRACT
This application seeks to support Caretia Washington, MD/PhD student, with a diversity supplement. Ms.
Washington is an African-American, U.S. citizen who is currently in a PhD program in Public Health at the
University of Florida, Gainesville. This supplement will support mentoring and supervised research experience
that will help her to become an independent investigator. Ms. Washington’s mentor will be Dejana Braithwaite,
PhD, MSc. In this diversity supplement, we propose to identify a retrospective cohort of stage I/II NSCLC patients
(n=2,000) in OneFlorida to provide the first detailed assessment of imaging surveillance utilization and survival
by levels of comorbidity and functional status as well as the first assessment of the impact of baseline levels and
changes in comorbidity and functional status on patient outcomes. Completion of this project will inform future
analysis of lung cancer disparities in the PLuS cohort. As the diversity supplement candidate, Ms. Washington,
will gain essential experience in epidemiology and cancer disparities as well as statistical methods used to
evaluate the multi-level causes of these disparities. Over a two-year period, Ms. Washington will engage in a
training plan to focus on the following objectives: 1) training in epidemiology methods, 2) training in quantitative
skills and statistical methods, and 3) professional development via grant and manuscript writing. The knowledge,
skills, and experience that I will gain by completing this training and research plan will make me a competitive
applicant for future career development awards such as F31, which is her next step in becoming an independent
health disparities researcher.

Public health relevance
PROJECT NARRATIVE A complex range of factors are associated with disparities in lung cancer surveillance. This research will identify targets for interventions designed to optimize lung cancer surveillance and outcomes among patients with early stage lung cancer.